Improving momentary suicide risk identification through adaptive time sampling

PROJECT SUMMARY/ABSTRACT
Suicide rates have risen sharply over the past 20 years1. There is a need to more precisely identify
proximal risk indicators for the development of near-term suicide risk in order to effectively intervene. Studies
utilizing ecological momentary assessment (EMA) to collect data at several intervals per day have demonstrated
that suicidal ideation (SI) and proximal risk factors change rapidly across the course of the day2. However, prior
EMA studies examining SI dynamics implement stable assessments, with intervals of several hours between SI
assessments across the duration of a study period3 for all participants. This one-size-fits-all approach to SI
assessment fails to capture the nuanced within-person variability of the timescale of the development of acute
suicide risk. In turn, we lack even a basic understanding of within-person variability in the time varying
relationship between SI and its proximal risk factors.
The proposed study aims to address the limitations of current assessment approaches in proximal suicide
risk research through the development of a personalized, adaptive time sampling system. The specific objectives
of the proposed research are to: (1) develop a novel, adaptive time assessment system that more efficiently and
accurately identifies when an individual is at highest risk for SI; and (2) advance the understanding of SI and its
theoretically-informed proximal risk factors at finer timescales. Data collected according to varied timing
schedules in the first phase will be used to train an algorithm that generates predictions of suicide risk, predictions
that will be adaptively use to determine assessment timing during the second phase of data collection. Aim 1 is
to develop the adaptive time assessment system, followed by assessing the predictive accuracy of the adaptive
sampling system (Aim 2) and identifying variations in person-specific effects of the relationship between SI and
theoretically-informed risk factors (Aim 3).
The research team (PIs: Ammerman, Jacobucci; Co-I: Cheng; Consultants: Burke) has access to world-class
expertise, with extensive experience in EMA data collection in high-risk samples, machine learning for suicide
prediction, longitudinal data analysis, collecting and modeling continuous data streams, and the development of
adaptive assessment platforms.
To meaningfully reduce suicide rates, a more nuanced understanding of suicidal thoughts and associated
risk factors is required. Our adaptive assessment platform will more efficiently assess suicidal thoughts and risk
factors, allowing for a closer approximation of the true associations. Indeed, there is a need to identify near-term
risk factors prior to suicidal thought occurrences to successfully deliver an intervention and prevent suicidal
outcomes. These findings will support the successful implementation of just-in-time adaptive interventions
through increased precision of suicide risk detection and targeted intervention timing. Given the grave personal
and societal cost of suicide, this work has important public health implications.

Public health relevance
PROJECT NARRATIVE The proposed research will address a significant health concern, the rise of suicide rates, by developing an adaptive time assessment system to provide a more nuanced insight into the time course of suicidal thoughts and prominent risk factors. NIH’s mission, and NIMH’s strategic priorities, will be served by the proposed study through enhanced identification of when individuals are at risk for suicide, allowing for early implementation of suicide prevention and intervention efforts and ultimately reducing suffering and mortality.